Oxidative DNA Damage And Its Processing

Oxidative DNA damage is implicated in brain aging, neurodegeneration, and other diseases. Damage can be created by normal cellular metabolism, which accumulates with age, or by acute cellular stress conditions, which creates bursts of oxidative damage. Telomeres, by virtue of their TTAGGG sequence, are hot spots for oxidative DNA damage. These types of lesions are removed from DNA primarily via the base excision repair (BER) pathway.

BER is carried out through four enzymatic steps, however several other proteins modulate BER efficiency through protein-protein interactions and post-translational modifications. We and others identified several protein interactions for the core BER enzymes. Thus, we are exploring mechanisms that stimulate DNA repair pathways since we believe elevated DNA repair capacity may thwart cell death, improve cellular fitness, and slow age-associated degeneration. We are continuing to explore the role of BER in mitochondrial DNA maintenance in disease states.